A Neuroecological Approach to Examining the Effects of Early Life Adversity on Adolescent Drug Use Vulnerabilities Using the ABCD Dataset

Project Summary
Early life adversity (ELA) is a multidimensional and potent risk factor for neurocognitive risk, downstream
drug use vulnerabilities, and adolescent drug use and misuse. The effects of ELA on youth’s drug use risk
depend on multiple dynamic family, peer, school, community, and sociocultural risk and protective contexts.
Yet, a significant knowledge base is missing to further our understanding of the contexts in which neural
biomarkers affect drug risk vulnerabilities and behaviors in adolescence.
Emerging research and theory implicate neuroregulatory systems that underpin emotion and behavioral
regulation as a powerful focus for adolescent drug use risk investigations. We focus on individual differences in
neuroregulatory systems whereby cognitive control networks become more effective over time in modulating
emotion processing networks, including the emotion/salience and reward salience networks. According to this
dual system view, a neuroregulatory imbalance between the socioemotional network (or ERSN, comprised of
the emotional, reward, and salience networks) and CCN ushers in diminished self-regulation abilities that
underlie drug risk behaviors in adolescence. This developmental mechanism and subsequent risk behaviors
may be differentially affected by youth’s dimensional stress. Extant developmental studies have cataloged
psychosocial risk and protective processes that moderate the impact of ELA and the development of drug use
vulnerabilities in adolescence. Yet ecological approaches remain rare in neuroscience approaches. Using a
developmental ecological neuroscience approach, we propose to investigate neurocognitive mechanisms that
mediate, and the contextual factors that moderate, the effect of ELA on drug-related vulnerabilities and drug
use. We will focus on the impact of ELA on developmental changes in functional activation and communication
(i.e., functional connectivity; FC) between the ERSN and CCN networks and its mechanistic role in leading to
adolescent drug use vulnerabilities and later drug use.
We propose to use a large, longitudinal dataset: the Adolescent Brain Cognitive Development Study
(ABCD; N=11,883; ages 9-10 at baseline and 11.5-12.5 at wave 6). We aim to test (a) the developmental
cognitive mechanisms that mediate the effect of ELA on drug use vulnerabilities and attendant drug use and
misuse (b) the moderating influence of family, peer, school, community, and sociocultural contexts on the
neurocognitive processes that lead to drug use vulnerabilities. Modeling multilevel latent change in ecological,
behavioral, and neuroimaging data is critical to further the precision and specificity of developmental models
and preventative intervention programs for drug addiction resilience in adolescence.

Public health relevance
Project Narrative The proposed project will inform public health research and practice on developing prevention and intervention programs that will mitigate the effect of adversity on adolescent drug use vulnerability and later drug use and abuse. In addition, our study will help determine the utility of neuromarkers to advance addiction prevention models via earlier and more accurate risk assessments.